Core C: Adjudication and Phenotype Harmonization

CORE C: PROJECT SUMMARY/ABSTRACT
The overall goal of the Adjudication and Phenotype Harmonization Core (Core C) is to generate the high
quality, analysis ready, clinical diagnoses and harmonized phenotypes. needed to develop the READD-ADSP
resource. Developing this resource is in line with NIA's mission to ensure that Alzheimer's disease gene
discovery represents all groups including those that have been traditionally underrepresented. Further, the
clinical deliverables from Core C will be invaluable to qualified investigators who access the READD-ADSP
resource. To produce these clinical deliverables, Core C will adjudicate 13,000 participants (cases/controls) from
US sites (n=8,000) and AfDC sites (n=5,000) and harmonize multi-domain phenotype data from the US and
African cohorts. The adjudication and harmonization objectives will be accomplished via two aims: (1) Acquisition
and processing of clinical data (e.g., data dictionaries and operation manuals) and metadata for adjudication and
harmonization; (2) Adjudication and harmonization of clinical data from US and AfDC sites and delivery clinical
diagnoses to Core E for distribution to Projects 1 & 2 and both clinical diagnoses and harmonized data to
NIAGADS for distribution to the ADSP-Phenotype Harmonization Consortium and the broader scientific
community. Ultimately, the value of the READD-ADSP resource resides in its potential to expand understanding
of AD genetics in underrepresented groups with implications for therapies that integrate personalized
information.